Cellular and molecular bases for rhythmic GnRH release

Reproductive health is a window to overall health. Fifteen to 20% of couples have difficulty conceiving; failures
of the reproductive system thus affect a substantial population. Beyond fertility, sex steroids alter development
and function of many systems, for example, bone, the central nervous system and the cardiovascular system.
Episodic release of gonadotropin-releasing hormone (GnRH) is required for fertility in vertebrates of both
sexes, and shifts in frequency of these pulses are essential for female reproductive cycles. The goal of this
proposal is to increase our fundamental understanding of the generation of episodic release of GnRH as a
critical link to understanding and modulating fertility. The proposed work will define intrinsic properties of GnRH
neurons, local network interactions, and roles of glia and postulated driver neurons located in the arcuate
nucleus of the hypothalamus that coexpress kisspeptin, neurokinin B and dynorphin (KNDy neurons). Our
working hypothesis is that intrinsic and network mechanisms interact in local circuits to produce the final
episodic output of the GnRH neurosecretory system. We will study this system using state-of-the-art
electrophysiological, imaging and chemogenetic approaches combined with local measures of GnRH release
in transgenic mice in which specific neurons are identified by expression of fluorescent reporter proteins. We
will also extend our studies with mathematical modeling to generate hypotheses and return these hypotheses
to the lab for testing. We have two specific aims. In Aim 1, we will examine how autocrine and paracrine
factors from GnRH neurons and glia alter the relationship among action potentials, intracellular calcium and
GnRH release, as well as how steroid feedback in males and females modifies these relationships. We will
apply this knowledge to study how GnRH neurons are coordinated to produce pulses. We hypothesize factors
from these circuit elements (GnRH neurons, afferent neurons, and glia) are needed for pulse generation. We
will use pharmacologic and chemogenetic approaches to study the specific roles of these elements in
organizing the GnRH network. In Aim 2, we will characterize intrinsic properties and synaptic input to GnRH
neurons in intact vs. castrate mice of both sexes. We will use these data to move beyond independent
characterization of isolated parameters and directly study how synaptic transmission interacts with intrinsic
properties of GnRH neurons to alter action potential generation. Dynamic clamp is a method that allows these
interactions to be studied. This is accomplished by careful modeling of these conductances, which can then be
added to and/or subtracted from cells during recording. This occurs in real time through iterative interaction
with the cell’s membrane potential, so that voltage-dependent changes in conductance are precisely controlled,
and effects of the conductances on the membrane potential and firing of the cell are recorded. By examining
pulse generation from these two angles, an integrated picture will emerge that adds to our understanding of
this phenomenon. All necessary animal models and methods are in place to complete these studies.

Public health relevance
Narrative The pattern of release of a hormone, gonadotropin-releasing hormone (GnRH), is critical for fertility. We are studying how this pattern is generated and how the timing is altered. This information can be used to help treat infertility.